Skeletal Myosin-Binding Protein C Regulation and Structural Dynamics

PROJECT SUMMARY
Arthrogryposis is present in 1 in 3,000 live births causing joint contractures in both upper and lower limbs.
There is no cure making it an unmet medical need. Mutations in the MYBPC1 gene encoding slow skeletal
myosin-binding protein C (sMyBP-C), expressed in both slow and fast muscle types are associated with
distal arthrogryposis (DA). MYBPC2 encodes for fast skeletal MyBP-C (fMyBP-C) and is found only in fast-
twitch muscle. As a myosin-anchored protein of muscle, MyBP-C extends toward actin, positioned centrally in
the sarcomere to regulate actomyosin interactions in force development. MyBP-C in skeletal muscle has three
major regulators: isoform (slow vs. fast), splice variant (long vs. short sMyBP-C), and posttranslational
modification (phosphorylation). sMyBP-C is phosphorylated by protein kinase A (PKA) at its N terminus. The
role(s) of sMyBP-C, its phosphorylation and DA mutations in skeletal muscle are not known. Our preliminary
studies of sMyBP-C show that binding to actomyosin is dependent on phosphorylation and DA mutations. We
have developed innovative biophysical tools that enable evaluation of skeletal MyBP-C structural dynamics,
actomyosin interactions in muscle, and effects of phosphorylation and mutations. Our new preliminary studies
demonstrate that we have successfully developed fluorescent sensors in N terminal sMyBP-C whose structure
and dynamics are sensitive to PKA-mediated phosphorylation and binding to actin. We have also developed
inter-molecular fluorescence assays that resolve actin binding between fMyBP-C, long sMyBP-C, and short
MyBP-C due to phosphorylation and the presence of tropomyosin on actin. These preliminary results suggest
key physiological mechanisms of regulation for the different skeletal MyBP-C and provides additional scientific
premise and feasibility for pursuing the proposed studies. Aim 1 will evaluate effects of sMyBP-C binding and
DA mutations on interactions with actomyosin, capturing structure and proximities of N terminal sMyBP-C,
actin and myosin. Spectroscopic probes will be placed in these proteins and approaches will be employed to
detect key conformations in vitro and in situ with wild type and DA mutant sMyBP-C. For fiber experiments,
muscle will be isolated from novel sMyBP-C knockout (KO) mice and permeabilized with recombinant sMyBP-
C, DA mutants, and muscle protein probes. Samples will be assessed for binding and contractile function. Aim
2 will determine how PKA-mediated phosphorylation of sMyBP-C affects the parameters evaluated in Aim 1.
Aim 3 will determine how fMyBP-C affects the parameters evaluated in Aim 1 except using fMyBP-C KO and
sMyBP-C/fMyBP-C double-KO mice for fibers experiments. The proposed studies capture structural dynamics
and interactions in real time and myofilament space using novel high-resolution approaches. These aims
outline a stepwise plan for studying normal and mutant skeletal MyBP-C during the contractile cycle. By
monitoring distances between points on proteins and the order (or disorder) of those distances under
physiological conditions, mutants can be separated into bins to facilitate targeted mechanistic-based therapies.

Public health relevance
PROJECT NARRATIVE We aim to determine the molecular requirements for healthy skeletal muscle function, in order to pave the way for discovery and design of more effective therapies for muscle disease and weakness. Our work will answer crucial questions about how the protein myosin-binding protein C (MyBP-C), a cause of distal arthrogryposis, functions in skeletal muscle, using reporter probes to visualize dynamic protein structures in contracting muscle cells. This research will greatly improve the human health prospects for understanding disease by determining effects of disease mutations and developing tools that can be used to discover novel treatments.